Role of necrosis in the evolution of highly metastatic and chemo-resistant breast cancers

High-grade, fast-growing breast cancers often display necrosis, usually within the tumor interior,
where perfusion, nutrients, and oxygen are limited. Recent studies indicate that necrosis is not
just an indicator of aggressive disease, but also a regulator of the aggressive phenotype, by
impairing cancer drug delivery, promoting genomic evolution, and instigating metastasis to distant
organs. However, we currently lack an understanding of the molecular mechanisms regulating necrosis
development and consequently, there are no therapies to prevent the development of necrosis and its
downstream effects on tumor aggression. For this application, we have developed animal models that
enable the robust dissection of the tumor-host ecosystem in the necrotic interior. Our studies
reveal that a secreted protein, angiopoietin-like 7 (Angptl7), is produced by tumor cells adjacent
to the necrotic core and is a regulator of tumor core vasculature development. Importantly, when
Angptl7 is suppressed genetically, tumor necrosis, tumor growth, and metastatic dissemination are
each drastically reduced. Thus, necrosis development is not inevitable but rather is preventable by
Angptl7 suppression. In the proposed work, we will combine studies using innovative animal models
and breast cancer patient blood and tissue samples to test the hypothesis that the development of
necrosis is a driving force for the evolution of highly metastatic and drug-resistant breast tumor
cells. In Aim 1, we will use mouse models to test the hypothesis that Angptl7-induced necrosis
limits delivery of chemotherapeutics to the tumor core, and that Angptl7 suppression synergizes
with neoadjuvant chemotherapeutics to improve drug delivery and improve tumor killing. In Aim 2, we
will use tissue from a large population-based cohort of early-stage breast cancer patients to
determine how dilated blood vessels, an indicator of Angptl7-induced necrosis, influences risk of
local and distant metastatic dissemination to predict benefit from adjuvant therapy. In Aim 3, we
will apply genomic sequencing and circulating tumor DNA analysis in an innovative rat model for
liquid biopsy studies to define the genomic signatures associated with Angptl7-induced necrosis.
We will then determine the prognostic impact of a circulating tumor DNA signature of necrosis in
human clinical samples. This work will define necrosis development as an engine for tumor
diversification and aggression, and the clinical contexts both in early stage and metastatic
settings where necrosis prevention could benetits patients with breast cancer and tumor types.

Public health relevance
Over 40,000 women die every year from aggressive therapy-resistant metastatic breast cancer. In this application, we will use animal models and patient samples to define how necrosis helps breast tumor cells mutate and spread to distant organs and spread to distant organs and determine whether preventing necrosis can block development of therapy resistance and tumor evolution.